MENTHOLATED CIGARETTES AND NICOTINE METABOLISM

The objective of this study is to determine the effects of smoking mentholated cigarettes on nicotine metabolism and on the intake of nicotine from cigarette smoking. This will be a three-week crossover study involving two brief GCRC admissions. During both admissions blood and urine collections will take place after a nicotine/cotinine infusion on the second day of each admission.